UAB NORC Core B: Metabolism

PROJECT SUMMARY – METABOLISM CORE
The Metabolism Core provides state-of-the-art, cost-effective, centralized analytical services to ongoing funded
and pilot nutrition-obesity research projects for assessment of human body composition, body fat distribution,
energy expenditure, substrate metabolism, physical activity, and exercise performance. Toward this end, the
Core maintains instruments, collects and provides quality control data, maintains and offers a web-based
scheduling system, and provides staffing by trained technical personnel for a broad suite of measures and
services that can accommodate the needs of small pilot studies and student projects up to large R01-level
protocols. In addition, the Metabolism Core promotes multidisciplinary research and training in clinical nutrition
and obesity across the UAB campus and offers training, advice, and instruction to students, fellows, and
faculty. Lastly, the Metabolism Core contributes to the development, evolution, and expansion of methodology
in fields of nutrition and obesity at UAB by implementing new technology and validating existing methodology in
specific populations.